Human Phenotyping Core

The principal goal of the Human Phenotyping Core is to provide high quality, innovative and state-of-the-art clinical phenotypes for NORC members The current objectives of the Core are to: a) Complete testing and validation of the procedures currently in development. b) Consolidate and finalize quality control procedures. In addition, we plan to maintain and consolidate our current quality control procedures, and strive to provide efficient and high quality services to NORC users. A major goal of the Human Phenotyping Core is to complete QC sheets (see Appendix VIM) for each phenotype. c) Develop fMRI - the major initiative of the Human Phenotyping Sub-Core in the next cycle will be to develop and validate functional Magnetic Resonance Imaging (fMRI) procedures. Dr. Steven Smith will devote 10 % of his time to this task and transition it to Dr. Ravussin and an Investigator with Physics Science expertise to be named.